Understanding How Metabolic Cofactors Control Cell Function and Fate

PROJECT SUMMARY
In the past two decades, the conceptual framework describing how metabolism interfaces with cell biology
has fundamentally changed. Once largely considered an adaptive process that conforms to energy demands
and cellular cues, it is now clear that metabolism itself can be an important regulator of cell function and fate.
This paradigm shift has been driven by studies showing that the concentration and localization of specific
metabolites can control physiological processes such as cell signaling, redox homeostasis, epigenetic and post-
translational modification, and antimicrobial immunity. Over the next five years, our goal is to apply these
principles to a widely-overlooked aspect of metabolism: metabolic cofactors. Cofactors such as coenzyme A
(CoA) and nicotinamide adenine dinucleotide (NAD+) are generally thought to exist in excess and merely as
passive facilitators of enzymatic reactions, with the exception of NAD+ as a substrate for deacetylases and DNA
repair enzymes. However, data generated during our previous project period inform our central hypothesis that
the abundance and localization of metabolic cofactors can regulate cell fate and function in entirely novel,
previously undescribed ways.
We will examine this concept in two subprojects. In the first, we will extend our findings that CoA is a Toll-
like receptor 4 (TLR4) agonist and test the hypothesis that CoA can act cell-extrinsically as a damage-associated
molecular pattern (DAMP) to prime macrophages for the resolution of inflammation. We will identify the genetic
and molecular mechanisms underlying this priming, determine the extent to which other metabolic DAMPs trigger
similar pathways and processes as CoA, and test whether interventions that increase physiological CoA levels
can promote resolution. In the second subproject, we will follow preliminary data showing that mitochondria from
pancreatic b-cells and neurons have an uncommonly high capacity for NAD+ transport across the mitochondrial
inner membrane. This informs our hypothesis that mitochondrial NAD+ transport in electrically excitable cells can
regulate vesicular exocytosis of insulin (b-cells) and glutamate (neurons). We will identify the mechanisms
underlying high mitochondrial NAD+ transport capacity in these cells, define the directionality of transport during
cell activation, and determine the effect of modulating NAD+ compartmentation on neuronal and b-cell exocytosis.
The proposed projects will further our laboratory’s broader efforts to study how metabolism can regulate cell fate
and function. Moreover, they will expand and evolve our understanding of the role of metabolic cofactors in cell
biology and disease.

Public health relevance
PROJECT NARRATIVE Metabolic cofactors such as coenzyme A (CoA) and nicotinamide adenine dinucleotide (NAD+) are mainly recognized for facilitating biochemical reactions, but work in our laboratory suggests that their concentration and localization can, in fact, control cell physiology. We propose that CoA can act as a signal to help resolve an inflammatory response, and cellular localization of NAD+ can regulate insulin secretion and neurotransmitter release. Successful completion of this work has the potential to change our understanding of the role of metabolic cofactors in cell biology, and could also have implications for diseases including inflammatory disorders, Type 2 diabetes, and neurological disease.